The Role of the Adrb3/IL6 Axis in the Impact of Psychosocial Stress on Lupus Pathogenesis

PROJECT SUMMARY
Psychosocial stress has been well-documented to correlate with systemic lupus erythematosus (SLE) flares
and poor SLE outcomes. How this occurs has not been well studied. We recently identified that psychosocial
stress induces circulating IL6 produced by Adrb3-expressing brown adipocytes. Brown adipocyte-derived IL6
mediates immunometabolic reprogramming through hepatic IL6 signaling to support “fight or flight” responses
to acute stress. We have generated preliminary data that chronic psychosocial stress may enhance mortality in
murine models of SLE through this novel Adrb3/IL6 pathway. Here, we propose to dissect the role of the
Adrb3/IL6 pathway in the impact of psychosocial stress on SLE pathogenesis in murine models. In addition to
gaining biological insight into how psychosocial stress leads to increased immune activation in lupus, our
studies would provide compelling pre-clinical data for potential human translation.

Public health relevance
PROJECT NARRATIVE How increased psychosocial stress worsens outcomes in patients with systemic lupus erythematosus (SLE) is poorly understood. We propose to test the role of a newly-discovered pathway that mechanistically links psychosocial stress and immunometabolic reprogramming in mediating the impacts of psychosocial stress on SLE pathogenesis.